Addressing the complexity and plasticity of heterotrimeric G protein signaling

SIGNIFICANCE— Signal transduction mediated by G protein-coupled receptors (GPCR) and
heterotrimeric G proteins (Gαβγ) is one of the most successful and versatile mechanisms of cellular
communication used across eukaryotes and animal organ systems. In humans, these pathways regulate a
myriad of physiological processes, from sensory perception to immune responses, and they are targets for
about one-third of clinically used drugs. However, our current understanding of these receptors and proteins
does not account for their remarkable flexibility in shaping cellular communication. Understanding the nuance,
diversity, and context-dependent nature of GPCR and G protein signaling would have broad and deep
implications for biology and medicine. The unifying goal of my NIGMS-funded research program is to
understand the molecular mechanisms that impart plasticity to GPCR and G protein signaling and to leverage
this information to imagine new ways to tackle human diseases.
PAST ACCOMPLISHMENTS AND FUTURE PLANS— We are uniquely suited to lead research in this
area based on our track record of perseverance and innovation: we have discovered new classes of G protein
regulators that shape responses triggered by GPCRs or (surprisingly) by other receptor families, developed
chemical and genetically-encoded probes to manipulate uncharted aspects of G protein signaling, and
designed state-of-the-art tools for measuring G protein activity with high fidelity and precision.
We will build on past experience and tools to advance in two areas related to G protein signaling
plasticity. Area 1 will be focused on an extreme case G protein signaling plasticity— i.e., activation of G
proteins independently of GPCRs. Here, we will define how widespread are the (patho)physiological
implications of the best-characterized family of non-GPCR activators of G protein signaling in vivo. For this, we
will use an innovative approach that combines multiple model organisms, including a novel transgenic mouse
tool. Area 2 will be focused on the development and implementation of complementary optical biosensor
platforms to measure GPCR signaling activity directly and with high spatiotemporal resolution in diverse,
physiologically-relevant systems without introducing major perturbations on signaling.
INNOVATION AND IMPACT— On one hand, this research program is anticipated to have a long term
impact by (1) revealing new mechanisms underlying G protein signaling plasticity in the absence of GPCRs, (2)
providing innovative tools for their investigation, and (3) establishing how their proper function is essential for
physiological homeostasis. On the other hand, the biosensor technologies developed through this program
could also transform how the large GPCR field approaches something as fundamental as recording signaling
activity, thereby allowing to gain a more reliable picture of this process across diverse experimental models
and accelerating translation of discoveries into biomedical applications.

Public health relevance
PROJECT NARRATIVE Heterotrimeric G proteins mediate the action of many neurotransmitters, hormones and pharmacological agents involved in normal physiology, disease, or therapy. Here we propose studies to elucidate new molecular mechanisms by which G proteins are regulated and to develop technologies that enable their investigation with unprecedented detail and fidelity.